Modulating miR-218 in human motor neurons using assembloids

PROJECT SUMMARY/ABSTRACT
In motor neuron diseases, neuromuscular junctions are lost and motor neurons degenerate resulting in
progressive paralysis and death. Post-transcriptional gene regulation by microRNAs (miRNAs) is hypothesized
to be disrupted in motor neuron diseases due to inherited mutations in proteins involved in miRNA processing,
such as TDP43, FUS, and SMN. Yet, the role of specific miRNAs in human motor neuron gene regulation and
function is not well characterized. I previously discovered that a single miRNA, miR-218, is uniquely enriched
and abundantly expressed in mouse motor neurons. Furthermore, mice lacking miR-218 exhibited deficits in
neuromuscular synaptogenesis and die due to muscle paralysis – phenotypes associated with motor neuron
disease. Subsequent studies have implicated miR-218 dysregulation as a mediator of motor neuron disease in
humans. However, the relationship between miR-218’s repression of target gene pathways and motor neuron
phenotypes has not been resolved, and the biological role of miR-218 has not been previously investigated in
humans, leaving an important translational gap in our knowledge of human motor neuron gene regulation and
function. In response to this challenge, we in the Pasca Lab have recently developed a three-dimensional, human
induced pluripotent stem (hiPS) cell-derived model of human motor neuron development and function, called
cortico-motor assembloids, by fusing cortical, spinal, and skeletal muscle spheroids. Dr. Amin proposes using
this novel system to model the impact of miR-218 upon motor neuron development, target pathways, and human
specific-features of post-transcriptional gene regulation. This proposal will leverage Dr. Amin’s existing
proficiencies in motor neuron development, miRNA biology, and advanced transcriptomics and will enable new
career development training in stem cell biology and human brain organoid models with mentor Dr. Sergiu Pasca.
Dr. Amin will utilize the exceptional research environment and resources available at Stanford University. He will
be supported by his advisory committee comprising of Dr. Howard Chang, an expert in non-coding RNA mediated
gene regulation, Dr. Aaron Gitler, an expert in motor neuron biology and disease pathways, and Dr. Richard
Reimer, a practicing neurologist and expert in disease pathogenesis. Completion of this proposal will pave the
way for further investigations into the therapeutic modulation of miR-218 and its target mRNAs in human motor
neuron disease.

Public health relevance
PROJECT NARRATIVE In motor neuron diseases, neuromuscular junctions are lost and motor neurons degenerate resulting in progressive paralysis and death. Dysfunctional microRNA (miRNA) processing has been implicated in their pathogenesis and I previously discovered that a single miRNA, miR-218, is uniquely enriched and abundantly expressed in mouse motor neurons and regulates neuromuscular function. I will utilize a novel human induced pluripotent stem cell-derived model of cortico-motor development to investigate the gene regulatory and biological functions of miR-218 in human motor neurons to gain insights into this essential miRNA’s role in human neurodevelopment and disease.